INFLUENCE OF CALCIUM ON BONE MASS FORMATION DURING PUBERTY

This study assesses the effects of increased calcium intake on bone mass formation in females during puberty and early adolescence via longitudinal, double-blind, placebo-controlled trial of calcium supplements.